Mechanisms of host leukocyte-mediated Toxoplasma dissemination in its host

The intracellular parasite Toxoplasma gondii causes life-threatening disease in immunosuppressed or
transplant patients. Its pathology mainly relies on the dissemination of the parasite from the site of infection to
various essential organs, such as the brain, where it causes tissue destruction. T. gondii often uses a Trojan
Horse mechanism to facilitate its dissemination, during which it hijacks the host cell migration machinery to co-
opt host leukocytes as shuttling vectors. Exactly how T. gondii does so, however, is largely unknown. We
recently identified a novel T. gondii protein important for its dissemination, which we named TgWIP. We found
that upon invasion the parasite secreted TgWIP into the host cell cytosol, where TgWIP stimulated dendritic
cells to become hyper-migratory and undergo a mesenchymal to amoeboid transition (MAT). The process was
associated with a dramatic rearrangement of the actin cytoskeleton. The overall objective of this application is
to determine the molecular mechanisms by which TgWIP mediates T. gondii dissemination in the host. Our
central hypothesis is that TgWIP promotes dissemination by modulating leukocyte actin dynamics. This
hypothesis was formulated based on our preliminary data showing that TgWIP directly interacts with several
central regulators of the actin cytoskeleton involved in cell migration, including the WAVE regulatory complex
(WRC), the SH2-SH3 adaptor proteins Nck and Grb2, and the SHP1/2 tyrosine phosphatases. We will test our
hypothesis by pursuing two aims: 1) determine how TgWIP interacts with various actin regulators to modulate
host actin dynamics in vitro, and 2) determine how TgWIP enhances host leukocyte motility to facilitate
dissemination in vivo. Specifically, our team will combine biochemistry, cell biology, and animal models to
determine (i) how TgWIP directly interacts with the WRC, Nck, Grb2, and SHP1/2, and how the interactions
influence actin polymerization in vitro; (ii) how these interactions alter the migrative behaviors of primary
dendritic cells; and (iii) how disruption of these interactions influences in vivo dissemination of T. gondii in mice.
Our proposed research is innovative because it will unravel a novel mechanism by which TgWIP, as a newly
identified parasite effector unique to T. gondii, coordinates several distinct host actin regulators to reroute
leucocyte migration and facilitate T. gondii dissemination. Our work is significant because understanding the
molecular and biochemical mechanisms underlying T. gondii dissemination will lay the foundation for the
development of novel interventions that can directly target these mechanisms and block T. gondii
dissemination after acute infection or reactivation in AIDS or transplant patients or from the mother to the fetus.
This knowledge will be also important for the development of a safe, non-transmissible live vaccine that can
prevent T. gondii transmission from animals. Furthermore, by understanding how TgWIP promotes MAT in
infected DCs, our work will provide valuable insights into how other cells, such as metastatic cancer cells and
leukocytes, may use a similar mechanism to undergo MAT in response to diverse environmental conditions.

Public health relevance
Narrative Toxoplasma gondii is an obligate intracellular pathogen that can cause serious disease in immunosuppressed people (such as AIDS patients) and fetuses and is also a major cause of blindness in otherwise healthy individuals. In this proposal, we will determine the mechanisms by which Toxoplasma uses the secreted effector protein TgWIP to modulate the host leukocyte migration machinery, thereby hijacking these cells as Trojan Horses to mediate its in vivo dissemination. By advancing our understanding of the molecular mechanisms by which Toxoplasma disseminates through co-opting host leukocytes, the proposed work can provide novel insights into cell motility, which is likely shared by various types of metastatic cancer cells and immune cells, and will also lay the foundation for the development of safe, non-transmissible vaccines or novel therapeutics to block Toxoplasma dissemination.